Critical Policy Gaps in the Earned Income Tax Credit: A Lost Opportunity for Improving Equity and Reducing Youth Violence and Child Abuse and Neglect

Project Abstract/Summary:
The Earned Income Tax Credit (EITC) plays a critical part in the social safety net by increasing ﬁnancial
security for low to moderate income working families, particularly the 5.4 million households headed by
single female parents with low education. The EITC has been identiﬁed as a promising primary
prevention strategy for preventing child injury and risk factors for youth violence. However, program
design fails vulnerable ﬁrst-time mothers. EITC payments are so limited for ﬁrst-time mothers that
researchers have used less educated, single ﬁrst-time mothers as the “control” group to establish the
positive impacts of the EITC. Our central hypothesis is that current EITC design contributes to higher
child abuse and neglect and youth violence and exacerbates health inequities for groups already
experiencing disproportionate burdens of violence. The EITC gap exists as women pregnant with their
ﬁrst child receive little to no EITC beneﬁt until 2-14 months following birth despite strong evidence that
stress, nutrition, and economic well-being during pregnancy and early infancy impact a lifetime of
outcomes including experiences with violence. Our long-term goal is to support the health and well-
being of families by equitably reducing experiences with violence. The overall objective of this
application is to estimate how EITC policy design impacts outcomes for ﬁrst children and how this
contributes to the disproportionate burden of violence. We update the existing literature on EITC eﬀects
with a combination of data sources and causal design and provide the ﬁrst estimates of the child abuse
and neglect and youth violence improvements possible by closing the EITC gap for ﬁrst-time mothers.
Speciﬁc Aim 1: To quantify child abuse and neglect and youth violence eﬀects that would be achieved
by closing the EITC gap for ﬁrst births.
Speciﬁc Aim 2: To understand community member perspectives on risk factors for child abuse and
neglect and youth violence including EITC eligibility.
Speciﬁc Aim 3: To estimate a simulation model of the costs and beneﬁts of closing the EITC coverage
gaps for ﬁrst-time mothers.
3.1: Assess the CAN and youth violence eﬀects of closing the EITC gap at the federal level.
3.2: Separately estimate impacts of the EITC gap for people disproportionately impacted by
violence based on disability status and race and ethnicity and assess the role of the EITC gap in
perpetuating disproportionate burdens of violence.

Public health relevance
Project Narrative: The Earned Income Tax Credit (EITC) is a robust primary prevention strategy for child abuse and neglect and youth violence for low- and moderate-income working families. However, the program largely excludes ﬁrst births to families that experience disproportionate burdens of violence during pregnancy and early infancy. There is a vital need for information on how this the gap impacts contributes to child abuse and neglect and youth violence and disparities in these outcomes.